Cystatin F expression on microglia is critical for constraining demyelination following viral infection of the central nervous system

Project Summary
Multiple Sclerosis (MS) is a debilitating autoimmune disease wherein activated immune cells mistakenly attack
the protective myelin coating on neurons. This results in scarring and the formation of lesions in the brain and/or
spinal cord that contribute to a host of symptoms that vary dependent on the location of the injury. The precise
etiology of MS remains unknown, though recent studies have pointed towards a combination of genetic and
environmental factors. Intriguingly, a strong correlation exists between previous exposure to Ebstein-Barr virus,
which increases the risk of developing MS by 30-fold. As this highlights a potentially important role that viral
infection may play in the initiation of MS, our lab utilizes a murine neurotropic JHM strain of mouse hepatitis virus
(JHMV) that results in an acute encephalomyelitis that is accompanied by gray matter involvement with infection
of oligodendrocytes, astrocytes, and microglia. JHMV persists in the white matter tracts of the spinal cord,
inducing demyelination resulting in hind-limb paralysis in mice. We and others have demonstrated previously
that microglia, a resident innate immune cell population that resides in the central nervous system (CNS), are
critical in constraining the immune response in demyelinating models of MS. Intriguingly, in areas of
demyelination undergoing remyelination, there is a significant upregulation of cystatin F (Cst7), a protease
inhibitor. While Cst7 is expressed on many immune cells, we’ve shown that microglia are the predominant source
of Cst7 in the brain. Thus, this proposal seeks to define the role of microglia-derived Cst7 in the context of a viral
infection with JHMV. We propose to infect novel transgenic conditional knockout mice for Cst7 on microglia and
wild-type animals with JHMV to determine the impact of Cst7 on the immune response. A combination of flow
cytometry and imaging modalities will be utilized to characterize differences in brain immune cell infiltration and
activation. The impact of the conditional ablation of Cst7 on demyelination and subsequent remyelination will be
assessed as well, using state-of-the-art techniques like spatial transcriptomics (Aim 1). Based on our preliminary
and published findings, we hypothesize that Cst7 expressed on microglia is host protective. Therefore, we also
propose to evaluate Cst7 as a potential therapeutic for demyelinating diseases by employing an overexpression
model. Cst7 will be overexpressed in microglia in mice infected with JHMV and the subsequent immune response
and myelination status will be evaluated using similar techniques as described above (Aim 2). Together, these
aims seek to evaluate the role of microglia-derived Cst7 in an effort to further delineate mechanisms of
demyelination and remyelination. As it is extremely rare for damaged neurons to undergo remyelination in MS,
defining these mechanisms further will provide invaluable insight for the advancement of new therapeutics.

Public health relevance
Project Narrative Multiple Sclerosis (MS) is a debilitating autoimmune disease impacting millions of Americans caused by inappropriate immune cell activity that destroys the myelin sheath coating on neurons. Current therapeutics on the market focus on preventing further neuronal loss as once these neurons are damaged, spontaneous recovery is very unlikely. Thus, this proposal seeks to elucidate further the mechanisms of demyelination and remyelination in an effort to provide targets for therapeutic intervention that will hopefully address the recovery of nervous system health.